Epigenomic and transcriptomic markers of aggressive prostate cancer among African American men

PROJECT SUMMARY
African American men experience a disproportionate burden of aggressive prostate cancer and
prostate cancer mortality when compared with European American men. The underlying reason for the
disparity is unclear and the ability to predict an individual patient’s disease trajectory remains limited. This
makes treatment decisions difficult, particularly as available treatments range widely from active surveillance to
radical prostatectomy, which can have severe consequences such as urinary incontinence and erectile
dysfunction. There is growing evidence to support the potential of DNA methylation (DNAm) and RNA
expression markers in prostate tumors to enhance prostate cancer prognostication beyond clinical factors, but
few studies to date have focused on African American men.
The present pilot study will leverage a unique patient population (>40% African American) and archival
radical prostatectomy prostate tissue from the University of Maryland Greenebaum Comprehensive Cancer
Center. Aims 1 and 2 propose to leverage array-based technology to investigate whether DNAm and RNA
expression markers can discriminate between aggressive (total Gleason score>=7) and non-aggressive
prostate cancer (total Gleason score<7) in African American men. We will use Gleason score as our endpoint
because it is available for all samples and because recent studies have supported its utility as an intermediate
endpoint in the discovery of prognostic markers. Aim 3 proposes integrated analyses of DNAm and RNA
expression data to investigate the hypothesis that some DNAm markers are associated with aggressive
disease independently of expression, thereby providing unique prognostic information.
The K07 mechanism will allow me to receive essential training in the integration/application of tumor
tissue biomarkers in epidemiological studies and analysis of high-dimensional data under the guidance of a
strong team of mentors with synergistic expertise in molecular epidemiology, prostate tumor biomarkers, high
dimensional data analysis and predictive oncology modeling. This project will also include an additional advisor
who is a genitourinary oncologist and basic science researcher in prostate cancer and will contribute to the
interpretation and assessment of clinical significance of findings. My previous research has focused on blood-
based biomarkers in targeted genomic regions and I will greatly benefit from specialized training in tumor
tissue markers and expanding to high-dimensional data as I move towards independence in molecular cancer
epidemiology. Moreover, this study will provide preliminary data that will build toward a larger (R01) application
in which I will integrate epigenomic and transcriptomic data for the discovery of novel biomarkers of aggressive
prostate cancer among African American men. My long-term goal is to lead studies that will promote improved
public health and reduce disparities in cancer outcomes through personalized medicine.

Public health relevance
Project narrative: The overall public health objective of this proposed study is to identify biomarkers that will improve risk- stratification for African American men with prostate cancer, who bear a disproportionate burden of aggressive disease and prostate cancer mortality, but have been underrepresented in previous studies. This research, in turn, will allow for more personalized treatment/management strategies that have potential to improve patient outcomes and reduce disparities in prostate cancer mortality.